2022 Congenital Muscle Disease Scientific Symposium

Cure CMD (Cure Congenital Muscular Dystrophy) seeks support from the National Institutes of
Health to collaborate with aligned patient advocacy organizations A Foundation Building Strength
(AFBS, focused on Nemaline Myopathy or NM) and Team Titin (focused on Titinopathy or TTN) for
the 2022 Congenital Muscle Disease Scientific Symposium, to be held June 30 - July 3, 2022. With
significant overlap in symptomatology, care management, and research communities,
representatives from each organization believe attendees will benefit significantly from information
exchange and collaboration.
The ultimate aim of the meeting is to accelerate progress toward clinical trials, treatments,
and eventually, a cure for congenital muscle disorders. The 2022 event would be the second
meeting of this type, and in the two years since the meeting, multiple advancements have been
made for each of the three conditions represented at the conference. Key objectives are to:
- Introduce new congenital muscle disease-focused research projects. The host patient
advocacy groups are funding 13 new research projects since 2019’s in-person convening;
- Discuss next steps for creating innovative platforms like the NCATS-led Platform
Vector Gene Therapy (PaVe-GT), taking advantage of common mutation classes and
pathophysiological pathways across CMD subtypes;
- Assess and update current subtype-specific research plans and priorities for each
disease, current since 2019, and highlight deficiencies in each on the path to clinical trials;
- Increase communication among researchers of rare neuromuscular disease. Though
these diseases are distinct from a histological and genetic standpoint, many treatment
modalities and interventions will be similar in nature. Information-sharing is key;
- Discuss research and opportunities for scientific advancement around cardiac and
pulmonary function, two systems that have the greatest impact on health and quality of
life for the congenital muscle disease community;
- Create, shape, and refine research projects and plans with clear patient input on
need and design. Discussions with affected individuals and clinicians will help ensure that
research is responsive to the community's needs.
With Cure CMD, AFBS, and Team Titin all working with researchers and industry to speed
toward clinical trials, these communities are primed for the next collaborative meeting.

Public health relevance
Having recognized significant overlap in symptomatology, care practices, and in their communities of researchers, three closely aligned patient advocacy groups—Cure CMD, A Foundation Building Strength (AFBS), and Team Titin—will host the collaborative 2022 Congenital Muscle Disease Scientific Symposium, in order to continue building momentum toward clinical trials for congenital muscular dystrophy, nemaline myopathy, and titinopathy. Following up on the inaugural 2019 collaborative symposium with similar goals, this meeting will be a focused opportunity, available online and in-person, for researchers to exchange information, spark dialogue, and launch new collaborations. Ultimately, through this meeting, we aim to contribute to better understanding of congenital muscle disease, speed toward clinical trials, help create better health outcomes, and serve as a model for other rare disease groups looking to build momentum toward treatments and a cure.